Analysis of the Pediatric Heart Network Echocardiogram Database to Establish Left Ventricular Strain Z-scores

PROJECT SUMMARY
In children, calculating ejection (EF) and shortening fraction (SF) using echocardiography (echo) is the
standard of care for evaluating left ventricular (LV) function. Despite their ubiquitous use, EF and SF are poorly
reproducible, calculated from multiple measurements each with their own error that is propagated, and
measure endocardial volume change without directly measuring contractility. Deformation strain is
fundamentally different from EF and SF. Instead of measuring volumes, echo software technology provides
speckle-tracking of myocardial movement to measure regional and global myocardial deformation to obtain LV
strain. Since this process is automated, it removes a large degree of observer-dependence. In addition, since
strain is a single measurement rather than a derived parameter calculated from multiple measurements, the
error for machine-derived strain should be substantially reduced. LV strain has been widely studied in adults
where normal reference ranges are validated and it is used to predict clinical outcomes and refine therapies. In
contrast, LV strain reference values based on a large, diverse population of children are not available and
strain remains largely a research tool in the pediatric population. To address this, we will establish Z-scores
using the PHN Echo Database. This database includes all images needed for LV strain measurements from
3526 echoes obtained in a well-characterized population of healthy children ranging in age from birth to 18
years. Z-scores account for the effects of maturation and growth by considering body size, age, gender, and/or
race when evaluating whether measurements are normal or, if abnormal, how many standard deviations they
deviate from the mean. Establishing Z-scores is the most powerful and flexible approach to normalizing
cardiovascular parameters for the effects of age and body size and has become the standard approach in
pediatric cardiology. We will determine if independent parameters such as age, height, weight, body surface
area, or heart rate can predict changes in LV strain with maturation and/or growth. To guide clinical use, we will
determine the feasibility and reproducibility of LV strain measurements for images collected as part of routine
clinical care rather than as part of a rigorous research protocol. We will evaluate the effect of sampling
frequency on Z-scores for clinically indicated studies by comparing those with ≥30 vs. <30 frames/heartbeat in
each age category. This project is highly significant and will impact nearly every pediatric subspecialty. LV
strain Z-scores will enable longitudinal studies to determine if LV strain is more predictive of outcomes than EF
or SF in children. If so, strain would move into clinical use and lead to a paradigm shift in the evaluation and
management of diseases where the child is at risk for LV dysfunction and subsequent heart failure. The PHN
database of normal echo images obtained as routine clinical care from a large, well-characterized population of
healthy children provides a unique, cost-effective opportunity to establish normal LV strain Z-scores and rapidly
deploy them for use in the real world setting of a busy pediatric echo lab.

Public health relevance
PROJECT NARRATIVE Because normal reference ranges are known, evaluation of cardiac strain has been valuable as an earlier detector of abnormal function and a better predictor of outcomes in adults at risk for heart failure. Obtaining normal reference values for growing children is more complicated and we will use an established database of echocardiograms obtained from healthy children across North America spanning all ages (birth to age 18 years) to establish ranges that will allow us to distinguish a normal measurement from an abnormal one. This project has the potential to completely change how we evaluate children at risk for heart failure and allow us to start treatment of the underlying disease earlier and adjust therapy more reliably for children with compromised heart function